ePanel License, Support and Maintenance, in support of the National Institutes of Health (NIH), National Cancer Institute (NCI), Division of Cancer Treatment and Diagnosis (CTEP), Cancer

In order to facilitate the review of NCI clinical trials, the NCI/CTEP requires licensing, support and maintenance for a web-based platform that includes an interactive agenda and related documents, customized review forms, voting and reporting functionalities, archiving of previous meetings, and a conference call speaker’s queue.